Comprehensive identification and functional study of Esrp-regulated isoforms during epithelial-mesenchymal transition.

ABSTRACT
Although over 90% of human genes undergo RNA alternative splicing, most studies fail to delineate the
various isoforms that are functionally important in the biological or pathological process under study. Past
efforts to identify isoforms were limited by incomplete sequencing read length, depth, or both. Meanwhile,
alterations of exon usage are critical regulatory mechanisms in biology with dramatic clinical consequences in
embryonic anomalies and cancer transformation. This failure to delineate the phenotype-causing RNA isoform
derangement is a particular barrier when investigating epithelial-mesenchymal transition (EMT), as we and
others have shown that Epithelial-splicing regulatory proteins ESRP1/2 are key regulators of RNA alternative
splicing and EMT. Loss of Esrp1/2 function abrogates alternative splicing in the embryonic epithelium termed
periderm, resulting in global alteration of mRNA isoforms in key EMT genes causing dramatic phenotype of
orofacial cleft malformation in humans, mouse and zebrafish. Since orofacial cleft is one of the most common
human birth structural anomalies, there is an urgent scientific and clinical unmet need to understand the
role of RNA alternative splicing and EMT with isoform level resolution and specificity.
This proposal leverages next generation long-read single-cell technologies and computation
approaches based on rigorous prior research to comprehensively identify RNA isoforms transcriptome-wide.
This proposal tests the central hypothesis that Esrp1/2 and Esrp-regulated isoforms modulate cell-cell
interactions necessary for EMT, translating to tissue morphogenesis changes in craniofacial
morphogenesis. To address this hypothesis, we applied long-read bulk RNAseq in zebrafish wildtype and
esrp1/2 mutants and identified tp63, gsk3bb and other candidate genes important in EMT. We will functionally
investigate these genes and their isoforms in complementary in vitro and in vivo models to mechanistically
elucidate their function in EMT. We will further identify lineage specific isoforms at a whole-transcriptome scale
using long-read single-cell RNAseq. We also developed a CleftTeq isoform panel using TEQUILA-seq, a rapid
and cost-efficient isoform identification and quantification technology we pioneered, to analyze 103 isoforms of
464 cleft genes in a proof-of-concept translation for clinical diagnosis of orofacial cleft.
The expected outcome of this project is to gain a mechanistic understanding of EMT with cell-type
specific isoforms and their dynamic function during EMT. This work will have a broad impact by identifying key
molecular drivers of EMT shared across biological contexts in development and disease. We will also translate
isoform identification and quantification to clinical diagnosis. Moreover, we will contribute public and searchable
single-cell RNA isoform database during EMT and inexpensive isoform gene panel technology, to broadly
share data and tools to catalyze investigations into the fundamental biological underpinnings of EMT.

Public health relevance
PROJECT NARRATIVE This project addresses critical knowledge gap to identify RNA isoforms that regulate epithelial-mesenchymal transition (EMT) during craniofacial morphogenesis. We will comprehensively identify genes and isoforms important for EMT and functionally test them systematically in complementary in vivo and in vitro models.